HIV Pathogenesis, Vaccination and Cure

Project Summary
This application represents the fourth competitive renewal for our T32 program “Training in HIV
Pathogenesis”. To reflect the vibrant development of our program, in step with NIH HIV/AIDS
research priorities as articulated in NOT-OD-15-137, we have renamed our program “Training in
HIV Pathogenesis, Vaccination, and Cure”. The program supports 6 predoctoral and 3
postdoctoral trainees per year. The program is based at the Perelman School of Medicine at the
University of Pennsylvania, the University of Pennsylvania School of Dental Medicine,
Children’s Hospital of Philadelphia and the Wistar Institute, which occupy a single, contiguous
campus in Philadelphia. Together, these institutions have one of the largest HIV/AIDS research
programs in the country, with a funding base of $49.5 million as determined by the NIH Office of
AIDS Research. Closely associated with our training program is our Center for AIDS Research
(CFAR) which was renewed in 2018 (i.e. $2.6 million annually), thereby supporting numerous
programs that benefit our trainees. Our program provides robust and innovate training in HIV
research, while integrating key concepts from numerous other disciplines. Appointments are for
1-3 years. Over the last 15 years, the program has supported 52 predoctoral students who
worked in 22 different laboratories and 27 postdoctoral trainees who have worked in 15
laboratories. Of these, 91% of graduate students and 91% of postdoctoral fellows are continuing
in research or research-related careers. Among the many individuals who study HIV/AIDS on
our campus, a select group of 24 mentors are associated with this T32 program. Excitingly, we
have added five new mentors in training (four assistant professors and one associate
professor), providing robust growth and new directions for years to come. In our program, we
place special emphasis on collaborative science and a commitment to training students and
postdoctoral fellows. The cohesive nature of our training program is demonstrated by the fact
that 22 of our 24 trainers have published papers with other trainers, and 69% of our trainees
over the last 10 years have published with two or more trainers. We are particularly pleased that
of our Diversity Trainees supported in the last 10 years (five predocs and three postdocs), all
are still in Research Related or Research Intensive careers. Based on these outcomes we feel
we are training young scientists effectively, and so propose to maintain the training program at
its present size.

Public health relevance
This application is for the fourth competitive renewal of our training program, now entitled “Training in HIV Pathogenesis, Vaccination and Cure”. Over the last 15 years the program has trained 79 distinguished young scientists, the great majority of whom are continuing in research. HIV/AIDS continues to be a severe health burden in the US and globally; experts on HIV/AIDS trained by our program are well positioned to lead the effort to reduce this disease burden.